Protein Biosensor Arrays Based on Nanomaterials

Measurements of proteins are of central importance in biomedical research, and disease-related applications include early detection, causal identification, and treatment monitoring. Sensitive, specific, fast, inexpensive detection of multiple proteins in patient samples is critically important for future public health. The broad, long term goals of this project are to develop ultrasensitive new array devices for accurate measurements of panels of proteins. Recent research has shown that panels of 4 to 10 biomarker proteins, as opposed to the single biomarkers now used, will provide much more reliable cancer detection and monitoring. We will develop and optimize microfluidic arrays for proteins that are accurate, cheap, and can detect multiple proteins at levels 10-100 fold lower than any commercial alternatives. This project targets arrays for small panels of biomarker proteins in serum and tissue, not proteomic biomarker discovery or analysis. In the past funding period, we developed nanoparticle-based strategies for ultrasensitive protein immunoarrays using many thousands of enzyme labels on magnetic particles for electrochemical detection, or dye-nanoparticle labels for electro-optical detection. We utilized prototype sensors and arrays to detect up to four cancer biomarker proteins in the serum of prostate cancer patients with high accuracy. We recently combined nanostructured sensor arrays with microfluidics and off-line protein capture by the multilabel magnetic-antibody particles. This powerful approach greatly decreases interferences and can detect biomarker proteins in serum at levels of 100 fg mL-1 (~3 fM), 10-100 fold below capabilities of commercial assays. Such high sensitivity provides new opportunities for detection of biomarkers with inherently ultralow levels. This renewal project seeks to translate our ultrasensitive protein detection approaches into the realization of widespread clinical, surgical, and research applications. The deliverables are optimized, validated microfluidic array devices for ultrasensitive detection of virtually any small panel of proteins. A high-speed array for detection of cancer cell metastasis (spreading) to lymph nodes during cancer surgery will also be developed. For proof-of-concept, specific devices will be designed to predict the probability of oral cancer from collections of serum samples, and to clearly distinguish between viral (humanpapilloma virus) and non-viral oral cancers. Patient and control samples obtained by our NIDCR/NIH collaborators will be used to establish clinical sensitivity and selectivity of the immunoassay devices. Summarized specific aims are: (1) Optimize microfluidic systems featuring nanostructured sensor chips and multilabel amperometry for an 8-protein oral cancer panel; (2) Design and optimize a simple electro-optical microfluidic array using dye-nanoparticle labels detected by electrochemiluminescence (ECL); (3) Establish clinical sensitivity and selectivity for oral cancer diagnosis for the best array systems; (4) Develop a rapid microfluidic assay for detection of a metastasis biomarker in lymph nodes. 1

Public health relevance
Project Narrative: Relevance to Public Health This project will develop ultrasensitive devices to detect collections of protein biomarkers in patient serum. It will provide new tools for reliable early diagnosis and monitoring of cancer to facilitate personalized therapy. It will also develop a rapid device to detect the spread (metastasis) of cancer. __SpecificAimsTextDelimiter__ Specific Aims Accurate measurements of proteins are of central importance in biomedical research, with applications including early detection and monitoring of disease, systems biology, and new drug development.1-4 Sensitive, specific, fast detection of multiple proteins in patient samples is critically important for public health. The broad, long-term goals of this project are to develop ultrasensitive arrays for semi-automated measurements of panels of proteins and related biomolecules. In the next funding period, we will develop and optimize microfluidic array devices, with the specific target of accurate, low cost detection of small panels of biomarker proteins for specific cancers with detection at levels 10-100 fold lower than existing commercial multiprotein assays. This project is not aimed at devices for proteomic biomarker discovery or analysis, for which other techniques are more appropriate,5 but at devices that accurately measure small panels of biomarker proteins in serum and tissue lysates for early cancer detection and treatment monitoring. The NIH defines biomarkers as "molecules that can be measured objectively as indicators of normal or disease processes and responses to therapeutic intervention".6 Recent research has shown that panels of cancer biomarker proteins, as opposed to single biomarkers, will be required for reliable cancer detection and monitoring.4,5,7-10 For example, detecting 5 or more biomarkers for a given cancer by liquid chromatography- mass spectrometry (LC-MS) can provide >99% reliable diagnostics.11-14 In contrast, currently used single biomarker proteins often have inadequate positive predictive value, e.g. ~70% for clinically approved biomarker prostate specific antigen (PSA).15 Thus, biomarker panels hold immense future value in their remarkable ability to distinguish between two or more biological states with low incidence of false positives and false negatives. There is a realizable hope that clinical biomarker panel measurements will help decrease deaths from cancer and improve therapeutic outcomes when coupled with targeted drug therapies.16-18 However, panels of biomarkers have yet to be broadly adapted to clinical use, mainly due to the lack of reliable, inexpensive multiprotein detection devices and protocols.19,20 In the past funding period, we developed complimentary amplification strategies for ultrasensitive protein measurements using thousands of enzyme labels on carbon nanotubes21 or magnetic particles22 for electrochemical detection, as well as dye-nanoparticle labels for electrochemiluminescence (ECL)23 detection. Combining single- and multi-label detection, we measured four proteins simultaneously with excellent accuracy in serum of prostate cancer patients using a non-microfluidic array.24 Key recent developments include: (a) combining nanostructured sensor arrays with microfluidics; and (b) using multilabel magnetic particle (MP)- antibody (Ab2) bioconjugates for off-line protein capture (see Progress Report). These powerful approaches were combined to detect cancer biomarker proteins in serum with detection limits (DL) as low as 100 fg mL-1 (~3 fM), 10-100 fold better than any commercial assay. Such high sensitivity provides new opportunities for detection of biomarkers with inherent ultralow levels. This competitive renewal project seeks to translate the ultrasensitive multifaceted approaches developed in the previous project period into viable multiprotein detection devices for clinical, surgical, and research use. The deliverables are optimized and validated microfluidic array devices for panels of proteins. Associated immunoassay protocols for simultaneous measurement of panels of proteins related mainly to oral cancer will be developed, but the devices will be applicable to ultrasensitive detection of virtually any small panel of proteins. A high-speed array protocol for detection of cancer metastasis biomarkers in lymph nodes will also be pursued. Unlike current commercial protein analyzers designed mainly for research, these microfluidic arrays will also be designed for clinical use. We will aim for high accuracy and sensitivity along with low cost to insure suitability for both clinical and research applications. As a proof-of-concept application, specific devices will be designed to predict the probability of oral cancer from collections of serum samples, and to clearly distinguish specific types of oral cancer. Cancer patient and control samples obtained by our NIDCR/NIH collaborators (see letter) will be used to rigorously establish sensitivity and selectivity of the immunoassay devices for cancer prediction using established statistical data analysis tools. Specific aims: 1. Optimize microfluidic systems fabricated with replaceable/reusable nanostructured 8-electrode chips and multilabel amperometric detection for the test protein panel. 2. Fabricate and optimize simple electro-optical microfluidic array using nanoparticle labels detected by ECL as an alternative system. 3. Establish clinical sensitivity and selectivity of microfluidic arrays for test panel of oral cancer biomarkers using cancer patient serum samples obtained by NIDCR with ROC statistical analysis. 4. Establish rapid microfluidic assay suitable for detection of biomarkers for surgical decision-making, using desmoglein-3 (DSG-3) in lymph nodes as a model biomaker for metastasized oral cancer cells. 2